Project 2: Rational approaches to improve treatment outcomes of patients with breast cancer brain metastases

Project Summary/Abstract
Brain metastases are a devastating complication with few effective therapies. Recently, antibody drug conjugates
(ADCs) have markedly improved outcomes for patients with metastatic breast cancer and other cancers.
However, patients with active brain metastases have been systematically excluded from most ADC trials.
Substantial preclinical and clinical data suggest ADCs may be effective against brain metastases due to their
ability to cross the disrupted blood-tumor barrier (BTB) in these lesions, unlike the intact blood brain barrier
(BBB). The compromised BTB in brain metastases enables entry of molecules including large biologics like
ADCs. Additionally, given our recent finding that PI3Kβ inhibition enhances anti-tumor immunity in PTEN-
deficient tumors, we will target immune evasion in PTEN-deficient brain metastases by evaluating PI3Kβ
inhibitors in combination with immunotherapy. Given frequent PTEN loss in breast cancer brain metastases
(BCBM), this approach has strong potential to improve outcomes for BCBM patients. We will leverage patient-
derived xenografts (PDXs) and genetically engineered models (GEMMs) to develop rational ADC-based
combination therapies for BCBM. In Aim 1, we will test combination approaches to increase the efficacy of the
HER2-targeted ADC, trastuzumab deruxtecan (T-DXd), in HER2+ and HER-low BCBM and evaluate PI3Kβ
blockade to enhance anti-tumor immunity. We will conduct clinical trials with T-DXd in patients with HER2+ and
HER2-low BCBM. In Aim 2, we will investigate the TROP2 targeted ADC, datopotamab deruxtecan (Dato-DXd)
in triple negative (TN) BCBM and evaluate combinations of Dato-DXd with PI3Kβ blockade in PTEN-deficient
TN BCBM. We will also pursue clinical translation of Dato-DXd in patients with TN BCBM. Our overarching goals
are to rigorously develop novel ADC-based therapies which are active intracranially in the preclinical setting to
enable rapid clinical advancement for this patient population with tremendous unmet medical need.

Public health relevance
Project Narrative The development of effective therapies for patients with breast cancer brain metastases remains a critical unmet medical need. Our preliminary data from preclinical and clinical studies suggest a role for antibody drug conjugates (ADC) in monotherapy and combination approaches to treat patients with brain metastases and suggest rational strategies to augment ADC activity by increasing payload expression and by targeting PI3Kβ to enhance anti-tumor immunity. Our overarching goals are to develop rational and effective strategies to dramatically improve outcomes in patients with this devastating site of cancer metastasis, not only in breast cancer, but potentially across multiple solid tumors.